Coronary Atherosclerosis and Immune Activation in HIV and Tuberculosis Infection

Project Summary
Persons living with HIV (PLWH) have a 1.5- to 2-fold increased risk of cardiovascular disease (CVD) compared
to the general population. Immune activation, particularly driven by coinfections, is considered an important
contributor in that enhanced risk. However, whether Mycobacterium tuberculosis (Mtb) coinfection increases
CVD risk in PLWH is unknown. Latent tuberculosis infection (LTBI) affects a quarter of the world population,
with coinfection rates as high as 50% in HIV-endemic areas. Our preliminary data point towards an important
role of LTBI in augmenting CVD risk. In HIV-uninfected individuals, we have demonstrated that LTBI is
associated with increased likelihood of acute myocardial infarction and higher prevalence of obstructive
coronary artery disease, independent of traditional CVD risk factors. In proof-of-concept mouse experiments,
we revealed that persistent, asymptomatic mycobacterial infection exacerbated aortic plaque development,
and that plaque burden directly correlated with alterations of monocyte populations. Our overall hypothesis is
that in PLWH, LTBI coinfection contributes to the development of atherosclerotic CVD (ASCVD) through
enhanced immune activation and pro-inflammatory stimuli resulting in increased plaque burden and instability.
In this project, we will study PLWH with and without LTBI in Lima, Peru, a TB-endemic area. In Aim 1 of this
proposal, we will define the burden of obstructive coronary artery disease and plaque vulnerability in PLWH
with LTBI using advanced coronary computed tomography angiography studies. In Aim 2, we will determine
how LTBI and LTBI treatment affects the activation, function, and metabolic profile of monocytes and Mtb-
specific T cells in PLWH, using high-dimensional multi-parameter spectral flow cytometry for in-depth
longitudinal immune cell profiling. Finally, we will study the relationship between variations on immune
activation markers and changes on coronary plaque volume over 2 years. Successful accomplishment of the
proposed research aims will define the role of LTBI as a contributor of ASCVD risk and immune activation in
PLWH. Our results will set the stage for targeted mechanistic studies and interventional trials aimed at safely
reducing underlying immune activation in PLWH with LTBI, and emphasize the importance of LTBI control as a
therapeutic strategy to mitigate ASCVD risk. Moreover, the knowledge gained will further enhance our broader
mechanistic understanding of ASCVD.

Public health relevance
Project narrative: Latent tuberculosis infection affects 1.7 billion people globally, and is a common coinfection in persons living with HIV. In this project, we will define the role of latent tuberculosis infection as a contributor of atherosclerotic cardiovascular disease risk and immune activation in persons living with HIV. We will therefore examine a prevalent, preventable, and treatable coinfection in persons with HIV to inform the design of future interventions to decrease the risk of cardiovascular disease in this population.